The Stanford Clinical Center for the Study of Type 1 Diabetes in Acute Pancreatitis

PROJECT SUMMARY/ABSTRACT
The Stanford Clinical Center (SCC) submits a renewal application to continue participation in the Type
1 Diabetes in Acute Pancreatitis Consortium (T1DAPC). The SCC will continue to recruit and retain
participants into the signature prospective observational cohort study – the Diabetes RElated to Acute
Pancreatitis and its Mechanisms (DREAM) study. The SCC will recruit into the optional arms of the
study including the mixed meal tolerance test arm, the frequently-sampled intravenous glucose
tolerance test arm, and the MRI imaging arm. The SCC will continue to work collaboratively to pursue
the comprehensive immunological analyses planned upon DREAM cohort completion. In anticipation
that DREAM enrollment will be completed in the next grant period, the SCC has assembled a multi-
disciplinary team including the disciplines of pancreatology, endocrinology, radiology, and
immunology to develop and complete current and forthcoming secondary and ancillary study
proposals approved by the T1DAPC Steering Committee.

Public health relevance
PROJECT NARRATIVE The Stanford Clinical Center will continue to actively recruit and retain participants into the signature observational cohort study of the Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC), named Diabetes RElated to Acute Pancreatitis and its Mechanisms (DREAM). Collected specimens from this cohort will be collaboratively studied to develop new immunological insights into the relationship between acute pancreatitis and diabetes. These insights will inform new diagnostic tests and treatments.